Implementing Sex, Sexual Orientation, and Gender Identity (SSOGI) Data Collection in Cancer Care (SSOGI Collect)

PROJECT SUMMARY
Sexual and Gender Minority (SGM) populations have higher levels of psychosocial distress and behavioral
chronic disease risk factors compared to non-SGM populations. These factors can enhance the risk for a
variety of chronic physical health conditions, including for cancer. While an increasing number of studies have
documented cancer disparities affecting SGM populations, such studies have often had small sample sizes
with recruitment limited to one health system or have recruited many participants online across a larger
geographic area but have lacked objective measures of cancer risk factors and outcomes. These
methodological limitations are directly attributable to the lack of high quality data capture of sex assigned at
birth, gender identity, and sexual orientation (SSOGI) across surveillance, health system, and research data
systems that monitor cancer. To achieve a paradigm shift in the rigor of SGM cancer studies, it is essential to
add SSOGI measures to cancer data systems and to engage in targeted efforts to scale up SSOGI data
collection. The Robert H. Lurie Comprehensive Cancer Center of Northwestern University (LCC) is one of the
nation’s leading cancer centers. Based in the Northwestern Memorial Healthcare (NMHC) health system, LCC
sees over 10,000 new cancer cases per year, including over 1,000 breast cancer cases annually. Within the
NMHC EMR and registration system, LCC has established infrastructure to capture SSOGI data. In March
2019, the NMH system transitioned multiple hospitals in NM’s network to EPIC as a unified EMR platform. All
hospitals using NM’s EPIC EMR system rolled out structured SSOGI data fields that could be completed by
NM staff or by patients via NM’s online patient portal, MyChart or the phone app, MyNM. Since the EMR
SSOGI question rollout, 8% of patients across the NMH system have SSOGI data on file. Our team of
researchers, clinicians, informaticists, and quality leaders at LCC and NMH have expertise in SSOGI data
collection and SGM health equity. We propose to accomplish the following specific aims in response to the NCI
SSOGI administrative supplement call: Specific Aim 1: Use a mixed methods Define-Measure-Analyze-
Improve-Control (DMAIC) quality improvement approach to identify barriers and facilitators for SSOGI data
collection at the patient, provider, and organizational levels within LCC/NMHC sites. Specific Aim 2: Train
LCC/NMH providers who see active cancer patients to administer SSOGI measures.Specific Aim 3: Use our
team’s established methods and partnerships with analytics to A) monitor SSOGI data completeness and B) to
develop and pilot an EMR equity report including SSOGI, race, ethnicity, age, insurance type, cancer stage,
and treatment status among active breast cancer patients seen at LCC/NMH. Successful accomplishment of
our aims will advance SGM cancer research and build a strategic foundation to advocate for expansion of
SSOGI data collection and to promote SGM cancer health equity initiatives.

Public health relevance
PROJECT NARRATIVE In October 2016, NIH declared sexual and gender minority (SGM) individuals a health disparity population for research purposes. While an increasing number of studies have documented cancer disparities affecting SGM populations, such studies have been limited by small sample sizes and lack of objective data capture about cancer diagnoses, treatment, and outcomes. Our team proposes to help fill this gap by scaling up sex assigned at birth, sexual orientation, and gender identity (SSOGI) data capture among active cancer patients and piloting the addition of SSOGI to breast cancer health equity EMR data reports within the Robert H. Lurie Comprehensive Cancer Center in the Northwestern Memorial Healthcare (NMHC) health system.